Hedgehog Signaling in Photoreceptor Differentiation and Maintenance

DESCRIPTION (provided by applicant): The Hedgehog (Hh) family of proteins plays important roles in the determination of neuronal cell fates and the maintenance of adult neural stem cell potentials. Previous studies and our preliminary results indicate that Sonic hedgehog (Shh) promotes retinal progenitor cell proliferation and affects specification of early born retinal neurons. However, the precise function of Hh signaling in mammalian photoreceptor cell development and survival is not well understood. The proposed research will use molecular genetic approaches to elucidate the roles of Hh signaling during mouse photoreceptor development and maintenance. The essential Hh receptor component Smoothened (Smo) will be eliminated by Cre/loxP recombination using transgenic mouse lines and retroviruses expressing Cre recombinase. The effects of disrupting Hh signaling on postnatal progenitor proliferation and cell fate commitment, and on photoreceptor differentiation and morphogenesis will be analyzed using molecular markers and electron microscopy. The roles of Hh signaling in photoreceptor maintenance and survival will be characterized by ablating the Smo gene or the Shh gene in the mature retina followed by functional and morphological analyses. Results of the proposed research will elucidate the function of an important signaling pathway in mammalian photoreceptor differentiation and survival. Moreover, these studies will provide new insights into mechanisms of photoreceptor degeneration and opportunities to develop novel therapies for combating retinal diseases. PUBLIC HEALTH RELEVANCE: The proposed research will study the influence of an important class of proteins called "hedgehog" on the formation and survival of photoreceptor cells, which undergo degeneration in various retinal diseases. The outcomes of these studies will enhance our abilities to protect photoreceptor cells and to direct the differentiation of neural stem cells towards functional photoreceptor cells for retinal disease therapy.

Public health relevance
Project Narrative The proposed research will study the influence of an important class of proteins called "hedgehog" on the formation and survival of photoreceptor cells, which undergo degeneration in various retinal diseases. The outcomes of these studies will enhanced our abilities to protect photoreceptor cells and to direct the differentiation of neural stem cells towards functional photoreceptor cells for retinal disease therapy.